STAT2 Signaling in the Pathogenesis of Psoriasis

Summary
Psoriasis
characterized
differentiation
Interferon
ISGF3
mice
cytokine
in
immunometabolic
STAT2
gene. Psoriatic
STAT2.
psoriasis.
drastically
by dermal infiltration of cells accompanied by hyperproliferation and abnormal
of keratinocytes. Along with the IL-23/IL-17/IL-22/IL-36 inflammatory signaling axis, the type I
(IFN-I) signaling pathway is another recognized driver of psoriasis. Assembly of the transcriptional
complex consisting of STAT1/STAT2/IRF9 mediates the expression of IFN-I target genes. Studies in
lacking type I IFN receptor (IFNAR1) or defective in IFNAR1 ubiquitination show IFN-I as a damaging
in psoriasis. Aside from being pro-inflammatory, IFN-I can reprogram lipid biosynthesis and alterations
lipid metabolism is an important factor in the pathogenesis of psoriasis; which has also been described as an
disease. STAT2 is a key signaling mediator of IFN-I signaling and emerging evidence links
to psoriasis.
skin lesions from patients display an IFN-I transcriptional signature and, notably, activation of
For this proposal, we present preliminary data depicting the pro-inflammatory nature of STAT2 in
Imiquimod (TLR7/8 agonist)-induced psoriasis-like skin inflammation in
attenuated
is an incurable multifactorial chronic inflammatory skin disorder of unknown etiology that is
immune
Genome-wide association studies have identified STAT2 as a psoriasis susceptibility
Stat2 deficient mice was
. Conventional dendritic cells (cDCs) are active players in psoriatic inflammation. We
show that deletion of Stat2 only in cDCs impaired TLR7/8 mediated maturation in vivo. Furthermore, we found
Stat2 to be critical for the psoriasis-associated cytokine IL-36 to enhance IFN-I signaling. In an unrelated study
on colon cancer, we show that Stat2 mediates the expression of pro-inflammatory cytokines IL1-β, IL-6, IL-17
and IL-22 and alters lipid metabolism. These latter findings lend support to the potential involvement of STAT2
in promoting inflammation and lipid dysregulation in the skin. Based on these observations, we will test the
hypothesis that aberrant STAT2 signaling contributes to the pathogenesis of psoriasis by disrupting
immune/epithelial homeostasis and altering lipid metabolite composition, thereby promoting an
inflammatory amplification cycle that leads to severe skin inflammation. For this proposal, we have
developed two specific aims in which we will employ conventional Stat2KO mice and our recently generated
conditional Stat2KO mouse. Aim 1 will determine whether Stat2 signaling in cDCs drives the generation and
reactivation of a Th17/IlL22 axis to obstruct normal keratinocyte maturation. Aim 2 will determine whether
Stat2 signaling in keratinocytes obstructs epidermal regeneration; preserves cell stemness and promotes
changes in lipid composition of the skin and incites an inflammatory positive feedback loop causing aberrant
immune cell activation. Significance: Successful completion of this project will bridge a significant gap in our
current understanding of STAT2 in the pathogenesis of psoriasis. We anticipate identifying novel inflammatory
markers for monitoring psoriasis, as well.

Public health relevance
Psoriasis is an incurable inflammatory skin condition that can severely affect quality of life. Although the triggers of psoriasis are multifactorial, genome-wide association studies and examination of skin lesions from psoriasis patients provide cues that implicate the signaling protein STAT2 in the pathogenesis of psoriasis. In this proposal, we will investigate this notion by employing a psoriasis animal model that mimics human disease.